Signaling at a distance mediated by vesicles on novel cellular protrusions

Abstract
The importance of elucidating the molecular mechanisms that underlie cell-to-cell communication
is impossible to overstate. Intercellular communication formed the foundation for the evolution of
metazoans; then as organisms grew larger, the transduction of signals over distance assumed
crucial importance. Long-range signaling in which cells must communicate accurately over
several cell diameters is vital both during development and for homeostasis. Deficiencies in the
proper execution of the process often results in disease or death. The study of human cancers
provides numerous examples of what can happen when a component of a signaling process goes
bad. Numerous signaling pathways have been characterized over the past few decades, and a
large number of the molecules involved in intercellular signal transduction, both extracellular
ligands and their cognate cellular receptors, have been identified. However, gaps still exist at
present in what is known of the means by which signals are propagated. The diffusion-based
propagation model suggested more than 60 years ago has been the dominant paradigm. This
has been particularly true in developmental biology regarding the impact of concentration
gradients that are predicted to form as signaling molecules passively diffuse through tissues.
Nevertheless, debate has continued on how well such models can explain the precision by which
various signals are transmitted over distances of multiple cell diameters.
Recently, several research groups including our own have shown that signaling molecules can
also be delivered accurately over such distances by direct cell-cell contact that involves the
extension of long, thin cellular protrusions (also referred to as signaling filopodia). We have
identified a novel variety of such protrusions extending from zebrafish pigment cells that we have
named ‘airinemes.’ Airinemes have been seen to be an indispensable component of stripe pattern
formation in zebrafish epidermis based on their mediation of long-distance Delta-Notch signaling
between pigment cell types. Intriguingly, we have also discovered that this airineme-mediated
long-range intercellular signaling is dependent on participation of skin-resident macrophages.
Collectively, our findings denote that mechanisms of signal propagation can involve much more
than mere passive diffusion of molecules. Moreover, we subsequently found airinemes protruding
from other cell types of the epidermis, e.g., keratinocytes, suggesting that airineme-mediated
signaling may be a general mechanism in at least that tissue if not others. Although the
airineme/macrophage-mediated signaling that we have described has been clearly validated as
occurring in vivo, the molecular and cellular details of how this signaling is accomplished are still
not sufficiently described. Those details are a crucial first step in linking anomalies in this mode
of signaling with the occurrence of various pathologies in vertebrates. In this proposal we will
address questions essential to establishing how airinemes achieve target specificity, whether
there is a particular subset of skin-resident macrophages that promotes airineme-mediated
signaling, and determining what functions airinemes provide in zebrafish keratinocytes. The
answers to these questions will not only expand our view of fundamental cellular strategies
employed in paracrine signaling but could also provide a basis for detecting where biomedicine
might be able to intervene in the process when signaling goes awry in human pathophysiology.

Public health relevance
Project narrative Long-range cell-to-cell communication is vital to all multicellular organisms during development and in maintaining homeostasis. Recent discoveries suggest that cells can communicate precisely and reliably via long, thin cellular protrusions. Our research has revealed such a process in zebrafish development that also requires the involvement of macrophages as signaling intermediaries. Studies proposed here will reveal underlying molecular mechanisms of cellular protrusion-mediated signaling and interrogate whether such signaling is generally utilized in other cell types.